Research Training in Pulmonary Immunology and Allergy at Massachusetts General Hospital

Research Training in Pulmonary Immunology and Allergy at MGH is a T32 renewal application that brings
together research programs of the Massachusetts General Hospital (MGH) Division of Pulmonary and Critical
Care Medicine (DPCCM), Allergy and Clinical Immunology Unit (ACIU), and Center for Immunology and
Inflammatory Diseases. This Training Program was created principally to provide comprehensive training for
physician-scientists in the DPCCM and ACIU fellowship programs interested in lung immunology and allergic
inflammation. The Program is designed to prepare the next generations of physician-scientists and PhD-
scientists to be leaders in lung immunology and allergy related research. In the first 9 years, this Program has
been highly successful with no unfilled slots and 100% rate of retention in academic centers or in industry
research. In addition, all but one former trainee who finished their T32 support more than 3 years ago have
published first author papers and submitted grant applications, and 50 research grants have been awarded. In
this renewal application we capitalize on this success and momentum and provide training in 12 scientific
disciplines: (i) Adaptive Lung Immunity; (ii) Innate Lung Immunity; (iii) Allergic Sensitization, Tolerance &
Immunodeficiency; (iv) Lung Injury, Repair & Regeneration; (v) Molecular Epidemiology & Genetics of Lung
Disease and Allergy; (vi) Health Care Delivery Science in Pulmonary and Allergy; (vii) Translational & Precision
Medicine; (viii) Systems Biology, Single Cell Genomics & Epigenetics; (ix) Microbiome; (x) Novel Imaging
Modalities; (xi) Metabolism; (xii) and Nanotechnology and Organoids. The Program will have basic, translational,
health outcomes and epidemiology components. Specifically, we seek to provide: 1) opportunities for mentored
research in disciplines that have the potential for high-impact discoveries; 2) outstanding research training
through didactics, seminars, and comprehensive mentoring; and 3) an environment and infrastructure that
fosters scholarly activity and career development into independent scientists. This application requests a
continuation of 8 training positions that will be allocated to trainees who are committed to 2 to 3 years of research
training. MD or MD/PhD candidates will be drawn from the DPCCM and ACIU fellowship programs. PhD trainees
will be chosen from postdoctoral fellows in the mentor laboratories who have demonstrated a commitment to
careers in pulmonary or allergy research. The 33 mentors (12 women, 4 underrepresented minorities in
medicine) in this Program were carefully chosen based on their track record of publications, grants, mentoring,
collaboration and interest in lung immunology and allergy. MGH provides an outstanding scientific and training
environment for its over 2,000 investigators and thousands of trainees with numerous training grants, research
centers, trainee support groups and over $1.2 billion in research grant awards. Furthermore, opportunities at the
nearby Harvard Medical School, the Harvard Chan School of Public Health, the Broad Institute, the Ragon
Institute and Massachusetts Institute of Technology provide additional valuable resources for trainees.

Public health relevance
Project Narrative Research Training in Pulmonary Immunology and Allergy at MGH is designed to prepare the next generation of physician-scientists and PhD-scientists who, through mentored research and rigorous training in new technologies, will be well prepared to be leaders in pulmonary immunology and allergy related biomedical research. The overall goal of the program is to educate trainees so that they can contribute to our understanding of the basis of inflammatory lung disorders and allergic diseases, and translate these findings to better clinical care for patients with these important diseases.